Optimizing prostate cancer care: integrating risks, benefits, and patient experiences in the new era of molecular imaging

PROJECT SUMMARY/ABSTRACT
A molecular imaging revolution is underway in prostate cancer. To overcome longstanding limitations in
prostate cancer staging, several positron-emission tomography (PET) scans have recently been approved and
rapidly integrated into clinical care based on evidence of improved diagnostic accuracy. However, the
consequences of widespread PET imaging are unknown. This is because the approvals of these tests are
based on improved diagnostic accuracy, a surrogate endpoint, rather than direct evidence of patient benefit. By
finding small sites of cancer earlier, PET imaging could introduce a cascade of effects—both positive and
negative—that could vary from patient to patient. PET imaging could lead to improved survival and fewer
symptoms from metastatic cancer in a subset, but could also increase treatment toxicity, psychological
burdens, and costs in others. Currently, no information is available to help guide patients or stakeholders when
considering these tradeoffs. To reduce these uncertainties, our goal is to develop a decision model that
considers the effects of PET imaging across multiple dimensions. To inform this model, we will generate real-
world evidence from a diversity of sources. In aim one, we will conduct complementary analyses of large,
nationally representative databases to evaluate the effectiveness of PET imaging, focusing on the associations
between imaging initiation of systemic therapy, progression to hormone-refractory disease, and costs. In aim
two, we will measure the longitudinal impact of PET imaging on patient-reported outcome measures relating to
psychological effects (anxiety and uncertainty) and health-related quality of life. To gain a deeper perspective
about patient experiences with testing we will also conduct longitudinal qualitative interviews among a smaller
subset of patients and integrate the findings from quantitative and qualitative sources. In the third study aim we
will incorporate inputs from Aims 1 and 2 to construct individual-based state-transition microsimulation models
examining common scenarios for PET imaging use. The outputs from these models will include estimates of
effectiveness, as well as patient characteristics that may be associated with greater or lesser degrees of
benefit or harm. The results of this study will equip patients, providers, and other prostate cancer stakeholders
with practical, new information about the potential short and long-term effects of PET imaging. If successful,
this approach for evaluating effectiveness will be applicable to other similar molecular imaging modalities that
will soon enter clinical care on the basis of surrogate endpoints of improved diagnostic accuracy, but without
evidence of long-term clinical efficacy.

Public health relevance
PROJECT NARRATIVE New, molecular imaging tests offering improved detection of prostate cancer are changing the management of the disease in ways that are not understood but have the potential for both positive and negative effects on patients and their disease. In this proposal we aim to understand the effectiveness of molecular imaging tests with the goal of helping patients and prostate cancer stakeholders make more informed clinical decisions that account for the cascade of effects that can be set into motion. To accomplish this, we will generate new evidence relating to the effects of PET imaging in the real-world setting, ultimately integrating this data in a decision model that will generate a clearer picture about the tradeoffs of imaging, including practical scenarios that are most or least likely to benefit patients.